Mechanisms of Dysregulated Innate Immune Responses to Lethal Infections

PROJECT SUMMARY
Microbial infections annually claim hundreds of thousands of victims in the U.S. alone, but its complex
pathogenesis is still poorly understood. Our seminal discovery of HMGB1 as a late mediator of lethal
endotoxemia (Science, 1999, Cited >4,000 times) has fueled continuous search for other late mediators of
lethal infections. With the long-standing R01 grant support from NIGMS (R01GM063075 for 15 years) and
NCCIH (R01AT005076 for > 10 years), we identified another late mediator of sepsis, Sequestosome-1
(SQSTM1) (Nat Microbiol, 2020). Meanwhile, we recently generated exciting preliminary data that
microbial toxins (e.g., the SARS-CoV-2 spike protein ACE2 receptor binding motif, RBM) and several host
secretory proteins [e.g., serum amyloid A (SAA), procathepsin-L (pCTS-L) and dermcidin (DCD)] divergently
affect the release of HMGB1 and SQSTM1 by innate immune cells. In line with the inspiring spirit of the MIRA
funding scheme, we wish to tackle bigger questions frequently considered as “higher-risk” or “ambitious” by
proposing a bold hypothesis that microbial toxins and host proteins induce the release of HMGB1 and SQSTM1
to trigger dysregulated pyroptosis, immunosuppression and coagulopathy. This hypothesis is built upon our
recent realization that extracellular HMGB1 causes macrophage pyroptosis and immunosuppression when
passively released in high levels (Sci Transl Med, 2020). Accordingly, we seek to address three key
challenges related to this hypothesis. The first involves the characterization of the dynamic changes of pCTS-
L, HMGB1 and SQSTM1 in parallel with other biomarkers in clinical sepsis using semi-quantitative
immunoassays or high-throughput Cytokine Antibody Arrays. The second involves understanding the
mechanisms by which microbial toxins (e.g., LPS and RBM) and host secretory proteins (e.g., SAA, pCTS-L and
DCD) divergently affect the release of HMGB1 and SQSTM1 by examining their effects on the expression of
macrophage hemichannels and secretory phospholipase A2s (sPLA2s), the activation of inflammasome and
pyroptosis, or immuno-metabolism. In the third project, we propose to evaluate the therapeutic efficacy and
protective mechanisms of DCD as well as cocktail of monoclonal antibodies against HMGB1, pCTS-L and
SQSTM1 in animal models of lethal endotoxemia, bacteremia, viral toxemia and sepsis. Elucidating the
mechanisms underlying the regulation of several late-acting mediators and development of novel cocktail
therapies requires a long-term commitment and associated flexibility to explore different research directions.
If successful, it will significantly improve our understanding of the intricate mechanisms underlying the
dysregulated innate immune responses to lethal infections, and shed light on the future development of novel
therapeutic strategies for the clinical management of human sepsis and other infectious diseases.

Public health relevance
Project Narrative The pathogenesis of sepsis remains obscure, but is partly attributable to dys-regulated systemic inflammation propagated by “early” cytokines (e.g., TNF and IFN-γ), but sustained by “late” mediators such as high mobility group box 1 (HMGB1) and sequestosome-1 (SQSTM1). The elucidation of novel intricate mechanisms underlying the regulation of late-acting mediators will significantly improve our understanding of mechanisms underlying microbial infection-elicited dysregulated innate immune responses, and provide clues for the development of novel therapeutic strategies for the treatment of sepsis and other infectious diseases.